Clinical Trials Engine to Develop an HIV Cure study to test engineered T cells

Project 4 - Abstract
The principle that adoptively transferred T lymphocytes have therapeutic promise for HIV infection
is well established. Our long range goals are to engineer T cells so that they can control HIV-1
replication in the absence of HAART. Our companies’ scientific founders have pioneered the use
of cell and gene therapy to treat HIV-1, and we will use this expertise to better study the
relationship between T cells that have been rendered resistant to HIV-1 infection and specific for
HIV to control of HIV-1 replication in the absence of ART. Our project serves as a main integration
site for this U19 consortium as the most promising approaches generated by Projects 1-3 will be
incorporated into Phase I clinical trial that we design, execute and analysis. Additionally, we will
develop a commercial T cell manufacturing platform that will give HIV infected individuals access
to Chimeric Antigen Receptor (CAR) therapy. The specific aims of this Project are: 1) Define the
optimal method to expand T cells for HIV cure studies: Using Tmunity’s T cell expansion expertise
and proprietary technology, we will systematically address the best media, artificial APC, and
manufacturing platform to develop an optimized protocol to expand highly functional T cells with
superior engraftment potential to be used as part of HIV cure regimens. 2) Design and
implement a Phase I clinical trial to test the ability of engineered T cells to prevent viral
rebound during an analytical treatment interruption: With input from the members of this U19,
scientific advisory board (SAB) and NIH program officers, we will plan and execute a Phase I
clinical trial that uses this new manufacturing protocol established in Aim 1. 3) Perform
correlative studies on samples collected in Aim 2 to develop testable hypotheses that
could improve adoptive T cell therapy for HIV infection: Using banked cells collected from
informative time points, we will perform validated assays that examine T cell function and
persistence and the ability of the chosen intervention to control HIV replication in the absence of
ART.